MicroRNA-200 family regulation by the apical-basal polarity complexes in EMT and

DESCRIPTION (provided by applicant): Lung cancer is the leading cause of cancer-related mortality, primarily due to metastatic disease. Developing improved metastasis prevention and treatment options will require a better understanding of the specific events involved in tumor progression and metastasis. We have shown that mice expressing mutations commonly found in human lung cancer (KrasG12D and p53R172H) develop metastatic lung adenocarcinomas. Cell lines isolated from tumors in these mice metastasize with high or low frequency following subcutaneous injection into syngeneic mice, dependent upon the expression of the microRNA-200 (miR-200) family members. Since the miR-200 members repress the Zeb family of transcriptional repressors, loss of miR-200 expression results in upregulation of epithelial-to-mesenchymal transition (EMT) genes and metastasis. Coincident with EMT, the metastasis-prone tumor cells lose expression of epithelial polarity complexes, and forced expression of miR-200 restores epithelial polarity and abrogates metastasis. Reciprocally, knockdown of a key component of the basolateral polarity complex, scribble, in a metastasis-incompetent cell suppresses miR-200, increases Zeb-1, and induces metastasis. These findings demonstrate a clear interplay between cell polarity, miR-200, and metastasis. Our global hypothesis is that functional apical-basal polarity complexes are required to maintain miR-200 levels and thereby suppress cancer cell EMT & metastasis. We will test this hypothesis by completing two Aims: Aim 1 will determine whether invasion and metastasis in scribble-deficient tumors is due entirely to loss of miR-200-mediated suppression of Zeb1; Aim 2 will determine whether miR-200 suppression and metastasis in the scribble-deficient tumors is due to loss of scribble itself, dysfunction of the larger basolateral complex, which includes the scribble (Scrib), discs large (Dlg1), and lethal giant larvae (Lgl1) proteins, or aberrant interactions of the basolateral complex with the apical polarity complexes, containing the crumbs homolog 3 (Crb3) or partitioning defective 6 (Pard6). A combination of 2D and 3D in vitro models, and syngeneic animal studies will be used to carry out this work, with the aim of understanding how the apical- basal polarity factors regulate cell phenotype through miR-200 fucntion.

Public health relevance
PUBLIC HEALTH RELEVANCE: Lung cancer is the leading cause of cancer mortality in the U.S., due mainly to the impact of disease metastasis to distant organs. Herein we propose to work with a new combination of in vitro and in vivo models to better understand the process of metastasis. Specifically we plan to study how migratory and invasive characteristics of the tumor are controlled by proteins that determine cellular architecture and cell-cell interaction. Lung cancer is the leading cause of cancer mortality in the U.S., due mainly to the impact of disease metastasis to distant organs. Herein we propose to work with a new combination of in vitro and in vivo models to better understand the process of metastasis. Specifically we plan to study how migratory and invasive characteristics of the tumor are controlled by proteins that determine cellular architecture and cell-cell interaction. __SpecificAimsTextDelimiter__ 10. Specific Aims Lung cancer is the leading cause of cancer-related mortality, primarily due to metastatic disease. Developing improved metastasis prevention and treatment options will require a better understanding of the specific events involved in tumor progression and metastasis. We have shown that mice expressing KrasG12D and p53R172H, which are common oncogenic mutations in human lung cancer, develop metastatic lung adenocarcinomas. Cell lines have been isolated from tumors in these mice, which metastasize with high or low frequency following subcutaneous injection into syngeneic mice. Relative to non-metastatic cells, the metastasis-prone cells have repression of the microRNA-200 (miR-200) family. Since the miR-200 family represses the Zeb family of transcriptional repressors, loss of miR-200 expression results in upregulation of epithelial-to- mesenchymal transition (EMT) genes. Coincident with EMT, the metastasis-prone tumor cells lose expression of apical and basal polarity complexes, and forced expression of miR-200 restores epithelial polarity and abrogates metastasis. Reciprocally, knockdown of a key component of the basolateral polarity complex, scribble, in a metastasis-incompetent cell suppresses miR-200, increases Zeb1, and induces metastasis. These findings demonstrate a clear interplay between cell polarity, miR-200, and metastasis. Our global hypothesis is that functional apical-basal polarity complexes are required to maintain miR-200 levels and thereby suppress cancer cell EMT and metastasis. We will test this hypothesis by completing two Aims: Aim 1 will determine whether invasion and metastasis in scribble-deficient tumors is due entirely to the increase in Zeb1 caused by miR-200 suppression; Aim 2 will determine whether miR-200 suppression and metastasis in the scribble-deficient tumors is due to loss of scribble itself, dysfunction of the larger basolateral complex, which includes the scribble (Scrib), discs large (Dlg1), and lethal giant larvae (Lgl1) proteins, or aberrant interactions of the basolateral complex with the apical polarity complexes that contain the crumbs homolog 3 (Crb3) and partitioning defective 6 (Par6) proteins. Aim 1: Determine whether invasion and metastasis suppression by scribble is dependent on miR-200 repression of Zeb1. Brief Plan: 1) We will knockdown scribble and force miR-200 expression in non-metastatic tumor cells (Scrib KD/miR- 200) to determine whether forced miR-200 expression is sufficient to revert the Scribble knockdown cells to an epithelial, non-metastatic phenotype in vitro and in syngeneic mice. 2) We will examine whether scribble increases miR-200 expression by transactivating the miR-200 promoter or does so indirectly by suppressing Zeb1. 3) We will compare the transcriptional profiles (mRNA and miRNA) of cells with forced Zeb1 expression, a potent suppressor of miR-200, to those with scribble loss-of-function to identify miR-200-independent actions of scribble. Aim 2: Determine whether the scribble-containing, basolateral polarity complex is sufficient to regulate metastasis or requires interactions with the apical polarity complexes to do so. A. Determine whether the basolateral polarity complex is sufficient to regulate Zeb1, miR-200 and metastasis. Brief Plan: 1) We will examine whether knockdown of basolateral polarity complex components that interact with scribble (Dlg1 or Lgl1) phenocopies the mesenchymal and metastatic properties of scribble KD cells in vitro and in syngeneic mice. 2) We will knockdown Dlg1 or Lgl1 in combination with Scrib to examine whether these components interact functionally to maintain cell polarity and suppress metastasis. 3) We will examine whether forced expression of miR-200 reverts the phenotypic changes induced by knockdown of the basolateral polarity complex proteins Dlg1 and Lgl1. B. Determine whether the basolateral complex regulates Zeb1, miR-200, and metastasis by interacting with the apical polarity complexes. Brief Plan: 1) We will examine whether knockdown of the basolateral complex alters the cellular localization of the apical polarity complexes. 2) We will examine whether knockdown of the apical polarity complex components crumbs 3 (Crb3) or partitioning defective 6B (Par6) phenocopies the mesenchymal and metastatic properties of cells with loss of the basolateral polarity complexes. 3) We will examine whether loss of apical polarity complexes alters expression of Zeb1 and miR-200. 4) We will examine whether Par6 inhibition by either knockdown or introduction of a dominant-negative mutant reverts scribble KD cells to non-metastatic, epithelial tumor cells.